Statistical machine learning tools for understanding neural ensemble representations and dynamics

The brain is a massively interconnected network of specialized circuits. Understanding how these circuits support
sensation, perception, cognition, and action requires measuring activity patterns within and across regions, but
the measurements themselves do not produce insight into the structure or function of the underlying neuronal
system. Insight requires the applications of quantitative methods that relate neuronal activity patterns to
experimentally measurable variables, including things like present and past sensory inputs, current location, and
current or future motor outputs. The result is an “encoding” model relating measured variables to spiking activity.
Through a simple application of Bayes rule, this encoding model can be used to create a “decoding” model. In
decoding, the goal is to take a pattern of spiking activity, along with a previously developed encoding model, and
assess the sensory, cognitive or motor representation corresponding to the spiking. Encoding and decoding
algorithms are a fundamental part of modern systems neuroscience and play a critical role in helping us
understand the nature and dynamics of neuronal representations. These approaches provide a powerful way to
gain insight about neuronal populations, but several limitations of current algorithms blunt their efficacy. First,
while modern deep neural networks can be powerful for decoding, they have multiple shortcomings in the context
of scientific discovery. Second, advanced decoding algorithms tend to be too complex and computationally
intensive for most researchers to implement in the analyses of large-scale neural datasets. Moreover, robust,
easy to use software that would allow less sophisticated users to take advantage of these algorithms does not
exist. Third, the results of decoding are typically very sensitive to the total number of neurons recorded. Fourth,
while decoding a single variable (e.g. animal position, target value, etc.) is tractable, decoding multiple variables
simultaneously is beyond the capacities of current approaches. Fifth, neural response properties and the quality
of neural recording often changes through the course of an experiment. Existing decoding algorithms are either
static or require repeated re-estimation of the encoding model to maintain estimation accuracy. Finally, decoding
has traditionally focused on observable signals, such as the animal’s position, but recent work has focused on
unobserved cognitive processes, such as mental exploration. New methods are needed to determine when
decoding of cognitive processes is reliable. Solving these problems requires new approaches and new
parallelized software that make these approaches easy to use and efficient for the community. We have
developed clusterless decoding algorithms that make very efficient use of the available data, and here we will
further develop those algorithms and the software that implements them to meet all of the challenges described
above. The result will be a powerful set of tools that have the potential to drive new discoveries.

Public health relevance
The proposed research will develop new software tools and algorithms for understanding how neuronal populations represent information and how those representations change over time. The resulting software will help drive new discoveries in our field.